Copper Catalyzed Fluorination of Aryl Halides

Project Summary. The aryl fluoride motif is prevalent in a range of important compounds. >25% of agrochemicals and >20% of pharmaceuticals contain fluorine, often in the form of aryl fluoride. Additionally, 18F is the favored radioisotope in Positron Emission Tomography (PET), an in-vivo imaging technique used in the diagnosis and treatment of diseases such as Alzheimer's and Parkinson's. Despite the widespread use of aryl fluorides in these areas, there are currently very few robust and functional group tolerant methods for their synthesis. Developing more efficient methods to introduce fluorine into organic molecules is therefore a priority. One promising method is the transition metal catalyzed synthesis of aryl fluorides from readily available aryl halides. However, there are few reported systems for this transformation. The two prior Cu-based systems use simple Cu salts and pose significant drawbacks that need to be addressed, such as the requirement for high temperatures, an excess of expensive fluoride source (AgF), supersoichiometric Cu, or limitation to specific directing groups. Developing systems that overcome these limitations is therefore an extremely important unsolved problem in the field. In order to improve on these systems, we aim to address key challenges inherent to Cu: (i) the instability of most CuIF complexes to disproportionation to form inactive Cu0 and CuF2 and (ii) the difficulty of the oxidative addition step. To overcome these issues we will move from simple Cu salts to well-defined copper complexes supported by N-heterocyclic carbenes (NHCs), cyclic alkyl amino carbene (CAACs), or related ligands. We hypothesize that these ligands will stabilize CuI intermediates, as well as favor oxidative addition, leading to more efficient catalysts. Specifically, we aim to use carbene-supported Cu complexes to: (1) study the effects of ligand properties on stoichiometric fluorination of aryl halides, (2) develop catalytic fluorination of a range of pharmaceutically relevant aryl halide scaffolds (3) synthesize 18F labeled tracer molecules for use in PET imaging. Completion of these aims will result in improved systems for the fluorination of aryl halides that can be applied to synthesis of pharmaceuticals, agrochemicals and PET tracers. Preliminary results have been obtained that support the feasibility of each proposed aim.

Public health relevance
Project Narrative. The synthesis of aryl fluorides is highly desirable because of their utility in diverse applications, such as pharmaceuticals, agrochemicals and positron emission tomography (PET). However, developing mild, efficient, and broadly applicable methods for the fluorination of aryl halides remains an important unsolved problem in the field. In this work, we aim to use carbene-supported Cu complexes to (1) study the effects of ligand properties on stoichiometric fluorination of aryl halides, (2) develop catalytic fluorination of a range of pharmaceutically relevant aryl halide scaffolds (3) synthesize 18F labeled tracer molecules for use in PET imaging.